Oncogenic triggers and their influence on 3D chromosomal architecture

PROJECT 3: PROJECT SUMMARY
Recent studies connected 3D nuclear and chromosomal architecture to the regulation of gene expression in
multiple tissues and cell types. PIs in this Program Project were some of the first to link 3D topology to cellular
transformation in human leukemia. We identified mutations that can impact DNA looping (targeting CTCF and
the Cohesin complex) and mapped nuclear topology in T cell leukemia (T-ALL). Also, in collaboration with the
Computational Core, we developed and refined computational tools that enable us to study such 3D interactions
in cancer genomes, starting with the characterization of large 3D structures, including chromosomal
compartments and topological associated domains (TADs). What we propose here is to move from higher-order
chromatin interactions to looping events that involve specific interactions between distinct DNA elements. More
specifically, we will focus on 3D ‘cis regulatory element (CRE) hubs’, DNA elements that interact with multiple
other DNA loci, including promoters and enhancers. We continue to focus on T-ALL but we now expand our
studies to related pediatric blood neoplasms, including early T cell progenitor (ETP), B cell-ALL (B-ALL), and, in
collaboration with Project 2, B cell lymphoma, all heterogenous blood cancers with distinct cells of origin and
phenotypic overlaps. We focus on transcriptional regulation of these neoplasms and test the hypothesis that
CRE hubs coordinate cell type specific gene networks serving as 'headquarters' of cell identity that contribute to
the control of transformation, tumor progression and response to drug treatment. We test this hypothesis in three
Aims. Initially, we map CRE hubs and study their biological significance as well as their relationship to genetic
background. Also, we study their intra- and inter-patient molecular heterogeneity of 3D hubs in leukemia, using
a battery of single cell tools and primary human samples. Finally, we propose a mechanistic understanding of
3D CRE hub function by targeting using in silico and CRISPR/Cas9-mediated approaches.

Public health relevance
PROJECT 3: PROJECT NARRATIVE In this project we focus on T cell acute leukemia-specific 3D “cis regulatory element (CRE) hubs”, DNA elements that interact with multiple other DNA areas, including promoters and enhancers. We hypothesize that CRE hubs coordinate cell type specific gene networks serving as 'headquarters' of cell identity and are able to control transformation, tumor progression and response to drug treatment.